Using Implementation Interventions and Peer Recovery Support to Improve Opioid Treatment Outcomes in Community Supervision

PROJECT SUMMARY Numerous studies have documented an increased risk of mortality following release from prison. However, considerable lags exist between the time that a death takes place and when cause of death information is reported in State Vital Records. Reporting delays prevent health departments from being able to proactively respond to public health emergencies as they arise. The main objective of this supplement application is to test a novel strategy for analyzing deaths in real-time using publicly available obituary data and web scraping technology. The following specific aims are proposed to expand the scientific impact of the parent grant 1) to scale up a web scraping tool that will link names of individuals recently released from incarceration with publicly available obituary and death information and 2) to validate web scraping linkage against a time period for which confirmed deaths are available, including the accuracy of determining cause of death via obituary data. The results of this project will enhance our ability to understand, in a timely way, all-cause mortality after release, including death from overdose.

Public health relevance
PROJECT NARRATIVE In the proposed project, we will scale up and test a novel method to characterize risk of all-cause mortality following release from incarceration by web scraping publicly available data. Results will determine if web scraping is feasible to conduct real-time mortality surveillance among people who have been released from incarceration.